Phase 3 Trial of DCA in PDC Deficiency IND 028,625 (02/04/2015)

Abstract
Congenital pyruvate dehydrogenase complex (PDC) deficiency (PDCD) is a life-threatening
mitochondrial disease of metabolic integration in which the efficient conversion of carbohydrate fuel into
energy is perturbed. There are no proven therapies for PDCD. However, dichloroacetate (DCA) represents
targeted potential therapy for this disease by stimulating residual PDC activity, decreasing hyperlactatemia
and improving mitochondrial energetics. This background and our preliminary data suggest that DCA may
benefit the clinical status of PDCD children. We have worked closely with the FDA and a parent-driven
organization to develop an appropriate study design and identify prospective subjects. We now propose to
undertake a 4 year phase 3 clinical trial to test the hypotheses that oral DCA will improve at-home
functionality of affected children compared to placebo and will be well-tolerated and safe for chronic use.
Our primary endpoint will be based on an improved clinical status, as determined by a novel, Observer
Reported Outcome (ObsRO) measure. Our secondary endpoints will include 1) confirmation of better
clinical outcome by the Karnofsky/Lansky performance scale of home functionality in children with life-
threatening disease; and 2) decreased lactatemia.

Public health relevance
Project Narrative Dichloroacetate (DCA) holds promise as the first potential therapy for pyruvate dehydrogenase complex deficiency (PDCD, a life-threating genetic disease in which cells die from a lack of energy created by mitochondria, the cells “power house.” We plan to conduct the first randomized controlled trial of DCA in young children (aged 1 month – 18 years) with PDCD, in collaboration with academic health centers across the U.S. If the trial shows DCA is safe and effective, it could lead to its use as the first FDA-approved drug for this devastating neurodegenerative disease.